Contextual factors influencing cannabis use and behavioral economic demand in the natural environment

PROJECT SUMARY / ABSTRACT
Heavy cannabis use is associated with higher likelihood of experiencing negative consequences, including
motor vehicle accidents and fatalities due to cannabis-impaired driving, adolescent emergency department
visits, cannabis-related psychosis, and cannabis use disorder. Understanding the factors that contribute to
greater cannabis use is a clinically significant and timely priority given expansion of legalization in the U.S.
Cannabis use and related problems are influenced by various contextual factors, including social context,
cannabis-related cues, and next-day responsibilities (i.e., personally relevant activities such as work,
caregiving, or academics). While much research has been conducted in laboratory settings, there is limited
understanding of the factors influencing cannabis use in naturalistic environments. This project aims to explore
these influences using behavioral economic purchase tasks and ecological momentary assessment (EMA).
This study seeks to extend laboratory-based behavioral economics research to the natural environment by
investigating the role of next-day responsibilities and upcoming activities on cannabis demand and
consumption, analyze whether the severity of cannabis use disorder moderates these effects, and determine if
cannabis formulations moderate these effects. The research team will conduct a 14-day EMA protocol with 100
community adults who use cannabis at least twice weekly. Participants will complete a morning report and 4
pseudorandom prompts per day, reporting on cannabis use and formulations consumed, cannabis demand,
and upcoming responsibilities and activities. These data will be analyzed using linear mixed effects modeling to
determine if the presence of upcoming activities or responsibilities and other contextual variables (e.g., social
context, current location) predict the level of cannabis demand and recent cannabis consumption reported at
the momentary level. Additional models will test whether increased cannabis use disorder severity (assessed
by semi-structured clinical interview for DSM-5 criteria) moderates the impact of responsibilities and context on
demand/consumption. Finally, we will test whether specific formulations (e.g., flower, edibles) also moderate
these associations. To our knowledge, no studies have incorporated cannabis demand assessments or
responsibilities into an EMA framework; thus, this innovation is expected to provide valuable insights into
factors influencing cannabis use in a naturalistic setting. Our results have the potential to significantly advance
contextualized behavioral economic models of cannabis use and provide clinically relevant insights into how
person-level factors such as upcoming activities, social situations, the type of cannabis consumed, and
addiction severity impact demand for cannabis and its consumption.

Public health relevance
PROJECT NARRATIVE Heavy cannabis use is associated with increased rates of negative consequences, including motor vehicle crash fatalities, cannabis-associated emergency department visits, cannabis-induced psychosis, and cannabis use disorder. Understanding the context surrounding cannabis use is important, considering that certain social situations, physical locations, and upcoming activities have been shown to differentially predict cannabis use and how much people value cannabis in laboratory studies. The proposed study will be the first to use mobile technology to examine how the reinforcing value of cannabis and its consumption are impacted by daily activities, social situations, and substance use contexts in the natural environment.